Idaho INBRE Administrative Core

Project Summary/Abstract Administrative Core Component
The Administrative Core will provide logistical support for the Idaho INBRE-4 Network and coordinate a
Bioinformatics Core, a faculty Developmental Research Project Program (DRPP), and a Student Program. The
PI/PD, PC, and Directors are well qualified with INBRE experience. A statewide Steering Committee includes
representatives from all 11 Network Institutions. The External Advisory Committee has scientific expertise,
mentoring experience, and knowledge of the research/workforce climate of Idaho. Together, this administrative
leadership will guide INBRE-4 decisions. The Administrative Core will build an environment to encourage
statewide/regional research collaboration and provide opportunities for faculty and students by: (i) facilitating
communication among investigators, (ii) coordinating training and mentoring for faculty and students, (iii)
overseeing research activities in Cell Signaling (the scientific theme), (iv) providing conflict resolution, (v)
prioritizing infrastructure needs, and (vi) assuring investigator access to state-of-the-art research facilities.
INBRE-4 will increase faculty research participation at all Network institutions with special emphasis at the
primarily undergraduate institutions (PUIs). The Administrative Core will oversee the Bioinformatics Core to
maximize facilities use and educational resources. It will coordinate the DRPP faculty development, setting
clear, attainable milestones to success, and facilitating interdisciplinary collaborations. It will manage the
Regional Alliance of INBRE Networks (RAIN), a new and innovative effort with Montana and New Mexico to
expand faculty and student opportunities, maximize regional Core use, and reduce redundancy. The Student
Program will provide a broad continuum of research opportunities, in both academic and industrial settings, to
generate and enhance a skilled, diverse workforce for Idaho. This program will also improve science curricula.
A series of interlocking progressively-intense student research experiences involve all 11 Network institutions
and comprise a “pipeline to health research careers” starting from K-12 through post-doctoral and medical
student training. Central to the Student Program is mentoring and career advising. Our current programs allow
any student in Idaho who has an interest in and talent for biomedical research to find an opportunity to pursue
that activity in Idaho. A high priority, to achieve this goal, is to promote diversity in the biomedical workforce by
recruiting and retaining trainees from under-represented groups and by supporting such individuals through the
academic pipeline at all stages. INBRE will build exceptional connectively with numerous complementary
programs such as COBREs, CTRs, Bridges, and SEPA. Evaluation is key to ensure INBRE resources are
used to maximum benefit, activities have high-value outcomes, and the scientific Network remains cohesive.
The Administrative Core will oversee a plan for internal and external evaluation and monitor/document
progress of the Cores and Programs. Summative outcomes will be used in formative evaluations to adjust
programmatic activities for continued INBRE-4 Network success to build Idaho's research capacity.